Biochemical Mechanisms for Sustained Humoral Immunity

Project summary
Antibody-secreting plasma cells play critical roles in health and disease, yet little is known
about the biochemical mechanisms controlling antibody synthesis and secretion or how
these pathways intersect with pathways controlling cell survival. Furthermore, due to the
high metabolic demands inherent to robust antibody secretion and the tendency for many
plasma cells to persist for decades, pathways restraining apoptosis in plasma cells are
likely to be integrated in unique ways. This project centers on the hypothesis that long-
lived plasma cells in bone marrow obtain requisite signals to maintain antibody secretion
and avoid cell death by sensing extracellular ATP with a purinergic receptor known as
P2rX4. We further hypothesize that eATP is produced locally in the bone marrow for
plasma cells by osteoblastic cells via the gap junction protein known as Panx3. Thus,
consistent with our preliminary data, inhibition of P2rX4 or Panx3 function is predicted to
cause the depletion of long-lived plasma cells and reduce serum antibody titers including
for disease-associated antibodies. To test our hypothesis, we will: 1) Define cell intrinsic
P2rX4-regulated outcomes for newborn and long-lived plasma cells, and 2) Define cell
extrinsic sources and outcomes for eATP/Panx3 regulation of long-lived plasma cells.
These studies will provide unique and needed insights into the specialized survival
mechanisms employed by long-lived plasma cells. This work supports our long-term
objective of developing strategies to effectively and specifically disable or deplete
problematic plasma cells.

Public health relevance
Project Narrative We will evaluate the role of the purinergic receptors P2rX4 in the survival and function of antibody-producing plasma cells. Our results should reveal novel strategies to deplete problematic and pathogenic plasma cells, and hence improve outcomes in autoimmunity and transplantation.